Novel Multiplex Biomarker Discovery Methods To Predict Breast Cancer Risk After A Benign Biopsy

Project Abstract More than one million women in the U.S. are diagnosed with biopsy proven benign breast disease (BBD) annually. BBD is associated with increases in BC risk, ranging from 1.5-2.0 times for least severe to fourfold for most severe categories. However, individual risk varies considerably within BBD categories. Previously, we developed the BBD-BC model, which provides individual risk estimates based on self-reported factors, detailed characteristics of BBD extent and severity, and assessment of involution (shrinkage and disappearance) of surrounding histologic structures termed terminal duct lobular units (TDLUs) from which most BC precursors arise. Increased levels of involution of TDLUs are associated with lower BC risk and limited data suggest that biomarker analysis of TDLUs in BBD biopsies may inform BC risk overall and potentially by BC subtype; however, this research has been limited by technical challenges. We hypothesize that by applying a novel quantitative multiplex protein measurement technology, NanoString Digital Spatial Profiling (DSP) to large core tissue microarrays (LC-TMAs) of TDLUs from BBD biopsies we can identify a prognostic biomarker panel to predict BC risk. DSP offers potential advantages over conventional immunohistochemistry, including improved quantitation and multiplexed analysis of 30 or more markers per tissue section, thus reducing tissue utilization. As proof-of-principle, we aim to technically validate candidate progression markers in the Mayo BBD cohort, which includes >14,000 women of whom >1,200 developed BC in follow-up over an average of ~15 years. We will construct LC-TMAs of 3 TDLUs for each of 50 BBD biopsies that preceded BC matched to comparable LC-TMAS derived from 50 BBD biopsies that did not progress. We will apply DSP to regions of epithelium and lymphocytes to assess multiple candidate progression markers in single tissue sections. We will perform conventional immunohistochemistry for the same markers, as one marker per section. We will include BC cell lines in LC-TMAs in which markers were measured by immunoblotting. We will compare agreement within and between methods (DSP vs. immunohistochemistry) and to immunoblotting and identify candidate markers that predict BC risk. Then, we will prepare similar TMAs of TDLUs surrounding BC and BC itself and evaluate the top markers that predicted BBD progression to assess whether these markers might be associated with tumor subtype. Combining DSP with LC-TMAs will enable analysis of multiple markers in multiple samples, efficiently and without exhausting tissues containing TDLUs, which are microscopic. This transformative proposal aims to develop and validate a method for quantitating protein in TDLUs using a cost-effective approach combining DSP and LC-TMAs, which will enable the identification and validation of candidate prognostic biomarkers for BBD. Improved BC risk prediction for women with BBD would facilitate precision management.

Public health relevance
Over one million women in the U.S. receive biopsy diagnoses of benign breast disease (BBD) annually, creating a pressing need to develop biomarkers to predict breast cancer (BC) risk for these women. Increased levels of involution of lobules in BBD biopsies are associated with lower BC risk and limited data suggest that biomarker analysis of lobules may inform BC risk overall and potentially by BC subtype; however, this research has been limited by technical challenges. We will develop and technically validate a novel approach for assessing biomarkers in BBD biopsies by applying quantitative multiplex protein measurement technology, NanoString Digital Spatial Profiling (DSP) to large core tissue microarrays (LC-TMAs) of lobules, thereby facilitating efficient biomarker assessment while limiting tissue utilization.